THE ROLE OF MG53 IN AVOIDANCE OF DISUSE-INDUCED MUSCLE ATROPHY

PROJECT SUMMARY
Extended periods of inactivity accelerate the progression of age-related loss of muscle mass, clinically known
as sarcopenia, and contribute to frailty. While antioxidant administration has been proven to reduce disuse-
induced atrophy, prolonged use is correlated with negative outcomes, including reduced mitochondrial
biogenesis in skeletal muscle, demonstrating a need for novel approaches to mitigate muscle loss during
conditions of disuse. A promising approach in this regard involves investigating the unique strategies that
hibernating mammals employ to maintain muscle integrity and function following 4-5 months of inactivity.
Seasonal-specific muscle proteomics of naturally hibernating thirteen-lined ground squirrels revealed an
increase in mitsugumin 53 (MG53) expression, a protein associated with mitochondrial protection in the
presence of reactive oxygen species (ROS). Of note, ROS have been shown to be a key factor associated with
disuse-induced atrophy, as they increase muscle protein breakdown (MPB) and depress muscle protein
synthesis (MPS). Although evidence clearly demonstrates the importance of inactivity-induced mitochondrial
ROS production, the mechanisms involved in its regulation are not well-understood. The exciting possibility
that upregulation of MG53 in hibernating mammals can improve mitochondrial health, reduce mitochondrial
ROS production, and prevent disuse-induced atrophy warrants investigation in a non-hibernating model
system. Informed by these findings, the overall goal of this research is to advance the understanding of
MG53’s role in muscle mass regulation during disuse-induced atrophy and lay a foundation for exploring its
role in sarcopenia and myopathies. The central hypothesis is that elevated MG53 reduces damaged
mitochondria through upregulation of autophagy beclin 1 regulator 1 (AMBRA1) expression, which lowers ROS
accumulation, leading to reduced MPB and allowing an increase in MPS during muscle disuse. To test this,
two specific aims will be pursued: (1) determine if MG53 is necessary to ameliorate disuse-induced muscle
atrophy; and (2) determine if MG53 is required for muscle regrowth following immobilization-induced muscle
atrophy. Expected results of the proposed studies will demonstrate that MG53 is a critical protein for skeletal
muscle recovery via improved mitochondrial function and AMBRA1 regulation. Ultimately, this work will
advance knowledge of the role of MG53 in mitochondrial ROS production and provide new therapeutic
opportunities for preventing muscle loss and dysfunction—ultimately improving quality of life among elderly
populations in the United States.

Public health relevance
PROJECT NARRATIVE Muscle atrophy is a common condition that negatively impacts the well-being of millions of people worldwide. Atrophy reduces strength, compromises physical capabilities, heightens fall risk, prolongs hospitalization, slows recovery, diminishes autonomy, and increases mortality. This research aims to investigate the unique strategies that hibernating mammals employ to maintain muscle function following 4-5 months of inactivity, toward identifying strategies for mitigating disuse-induced muscle atrophy in humans.